Preclinical efficacy of progestins in endometrial cancer

PROJECT 1 SUMMARY / ABSTRACT: Efficacy of Progestins in Preclinical Models of Endometrial Cancer
Uterine endometrial cancer (EC) incidence and mortality are on the rise worldwide. Deaths due to EC recently
overtook ovarian cancer, which makes EC the deadliest gynecologic cancer. Surgery is the frontline treatment
for EC, followed by surveillance or adjuvant chemotherapy/radiation. Surgery alone has historically been curative
for patients with differentiated endometrioid EC and also the precursor lesion, atypical endometrial hyperplasia
(AEH), which is a major health concern due to its high rate of progression to EC. However, the obesity epidemic
is accompanied by an increasing number of patients with medically complex comorbidities that limit surgical
options. Furthermore, surgery includes complete hysterectomy, which is a significant concern for patients who
desire childbearing. Therefore, there is a critical need for better conservative non-surgical management
strategies that can effectively prevent the transition of AEH to EC as well as prevent progression of EC. Hormonal
therapy with synthetic progesterone mimics, termed progestins, is currently the only viable non-surgical approach
and only pharmacological agent FDA-approved for the treatment of primary EC-AEH. Nearly 75% of patients
initially respond to progestin therapy, yet up to 40% of these patients later recur. Hence, the currently used
progestins have only moderate efficacy in controlling EC-AEH, suggesting that studies are necessary to identify
progestins that produce a sustained response and overcome resistance. Our objectives are to 1) establish the
preclinical efficacy of repurposed progestins in EC; and 2) identify new opportunities to achieve a more durable
progestin response and identify agents that can overcome resistance. In Aim 1, we will determine the efficacy of
progestins to decrease proliferation, promote differentiation, induce apoptosis and blunt tumor growth in
preclinical models of EC-AEH. Aim 2 will identify agents that potentiate the anti-proliferative effects of progestins
and overcome resistance. The expected outcome for Project 1 is to identify clinically used progestins that
promote tumor regression by blocking cancer cell proliferation and promoting differentiation. In addition, we will
also discover combinatorial regimens to mitigate resistance and search for novel progestins for future clinical
study. This work is anticipated to have a positive impact on the future treatment of EC-AEH by providing the first
comprehensive comparison of different progestin agents using clinically relevant EC-AEH specimens from
patients. Importantly, this project synergizes with the other P01 Projects both by providing key knowledge on the
cellular consequences of progestins in the endometrium and incorporating insight (e.g., targets for combinatorial
treatment) and specimens from other Projects.

Public health relevance
PROJECT 1 NARRATIVE: Efficacy of Progestins in Preclinical Models of Endometrial Cancer Incidence and mortality for uterine endometrial cancer are on the rise worldwide, and hormonal therapy is currently the only viable non-surgical approach. However, current hormonal therapies do not effectively prevent relapse, and they also increase the risk of breast cancer. Using state-of-the-art preclinical models, Project 1 will repurpose hormonal therapies used for other indications (contraception, hormone replacement therapy) to identify the ideal hormonal therapy, thereby making a critical contribution to the future of endometrial cancer prevention and treatment.